Mapping Subject-Specific Structural and Functional Connectivity to Parse the Unique Contributions of Subconcussive Blast, Mild TBI, and PTSD

ABSTRACT
Subconcussive blast is, by definition, not associated with acute or chronic phase symptoms. However,
neuroimaging offers initial evidence of damage to white matter following subconcussive blast. As with mTBI,
subconcussive blast is associated with tremendous spatial and inter-individual heterogeneity resulting from
variability in the events surrounding blast. A significant limitation of subconcussive, mTBI, and PTSD
neuroimaging research results from the comparison of group-averaged data of affected individuals to matched
controls that tends to mask individual-specific features. Fortunately, recent methodological advances in the
acquisition and analysis of resting-state fMRI (rs-fMRI) now offer an unprecedented ability to map individual-
subject-level functional connectivity. Long rs-fMRI scans (> 25 min) coupled with advanced individual-specific
parcellation methods provides quantification of inter-subject heterogeneity. 210 veterans from 4 subject
categories: (1) subconcussive (2) concussive mTBI (3) unexposed controls and (4) blast-unexposed PTSD, will
undergo (1) long rs-fMRI scans, structural MRI, diffusion MRI, (2) assessment of blast exposure, head impact,
and associated clinical symptoms, (3) psychiatric symptoms, and (4) a neurocognitive battery. In Specific Aim
1, we will compare individual-specific maps of functional and structural networks in every subject and between
the 4 subject categories. We hypothesize unique patterns of functional and structural connectivity among
individual subjects in each category. In Specific Aim 2, we will measure the congruence between structural and
functional network architectures. We hypothesize that the structure-function uncoupling in subconcussive and
mTBI groups will originate from structural alterations but the source of uncoupling in PTSD will be from
functional alterations. In Specific Aim 3, we will relate functional and structural network connectivity to the
events surrounding blast exposure, mTBI symptoms, PTSD symptoms, PTSD symptom clusters, depression
symptoms, other neuropsychiatric symptoms, and neurocognitive performance. Support vector regression
methods will train algorithms capable of recognizing individual-specific features of functional connectivity,
structural connectivity, and structure-function coupling that correspond to the subconcussive, mTBI, PTSD, and
control groups. An overwhelming challenge in the diagnosis and clinical management of veterans, is
delineating a complex array or overlapping exposures, histories, symptoms, and clinical signs into distinct
etiologically defined diagnostic entities. We propose analytic methods for unraveling heterogeneity, which
index brain network connectivity metrics derived from neuroimaging. We are taking important strides toward
discovering knowledge that is essential to future development of effective treatments and clinical management.
Mapping individual-specific etiologic pathways and mechanisms of disease will move us one step closer to
implementing precision medicine for Veterans’ health.

Public health relevance
NARRATIVE Mild Traumatic Brain Injury (TBI) from exposure to explosions, bombs, and blasts is experienced by a large number of returning military veterans. Some veterans experience symptoms immediately following exposure to the blast (concussive TBI) whereas others experience no symptoms in the immediate aftermath of the exposure (subconcussive TBI). We plan to study the effects of subconcussive and concussive blast exposures on the brain by using MRI to image both functional and structural connections within the brain. Using advanced brain imaging, we plan to map the functional and structural connections in the brain to determine the relationship between brain connections and the blast events. Discovery of these relationships will stimulate future discovery of treatments that are optimally tailored to the mechanism and type of injury.